Diagnosing the Unknown for Care and Advancing Science (DUCAS)

ABSTRACT
The proposed project aims to address the challenges faced by approximately 30 million individuals in the
United States with undiagnosed or rare diseases by extending best practices from the Undiagnosed Diseases
Network (UDN) model. We seek to enhance access to evidence-based diagnostic, research, and care
practices, especially for historically underserved populations, through implementation science frameworks.
Specific aims include developing a framework for a learning health network, increasing access for underserved
communities, leveraging advanced technical solutions to enhance diagnosis and care, and ensuring continuity
of care for participants awaiting diagnosis. Methods involve evaluating implementation science frameworks,
gathering participant perspectives through qualitative methods, developing technical solutions, and supporting
ongoing research studies. Long-term objectives include integrating UDN methods into broader clinical practice
and improving outcomes for individuals with undiagnosed and rare diseases.

Public health relevance
PROJECT NARRATIVE Patients with rare and undiagnosed conditions often face significant challenges in receiving proper diagnosis and care and accessing research opportunities, resulting in poor outcomes and straining healthcare resources. Through this project, we aim to leverage implementation science frameworks to extend the reach of the Undiagnosed Diseases Network (UDN), improve access for underserved communities, develop technical solutions tailored to the needs of the undiagnosed and rare disease community, and ensure ongoing research and care continuity for participants awaiting diagnosis.